Neuroimmune mechanisms of coronavirus-induced lung inflammation and airway dysfunction

PROJECT SUMMARY
The global impact of the COVID-19 pandemic has been profound, with nearly 800 million infections and seven
million deaths worldwide. With the majority of fatalities resulting from respiratory failure, there is a pressing
need to understand the factors that promote respiratory dysfunction following infection. The current paradigm
centers on immunopathological mechanisms behind disease, but fails to incorporate how sensory neurons
change during infection and contribute to the hallmark immune dysregulation and airway inflammation that
characterize severe COVID-19. Airway sensory neurons are robustly activated by inflammatory mediators,
pathogens and noxious irritants to modulate respiratory tone and initiate defense reflexes like cough, mucus
production and bronchoconstriction. They also regulate the immune response to pathogens in the lung and
become aberrantly activated during airway inflammation, thereby exacerbating reflex symptoms that contribute
to morbidity. However, whether they play a role in the pathogenesis of coronavirus disease has not been studied,
despite the potential to impact our understanding of airway physiology and identify new avenues for treatment.
This proposal will test the following hypotheses: 1) that lung-innervating sensory neurons
regulate the immune response to promote airway inflammation in coronavirus infection and 2)
during infection, these cells undergo functional changes that contribute to respiratory
dysfunction. Using the MHV-A59 mouse coronavirus infection model, our preliminary data support this
hypothesis by demonstrating that the systemic ablation of TRPV1+ sensory neurons improves airway function
while attenuating mortality and disease in infected mice. I will expand on these results by performing a specific,
targeted ablation of the lung-innervating sensory neurons to elucidate their role in coronavirus disease
pathology. I will determine if lung-innervating sensory neurons regulate airway inflammation by learning and
performing spectral flow-cytometry to profile and quantify pulmonary immune cells, while separately measuring
viral titer, neuropeptide and inflammatory cytokine concentrations in the lungs of infected, airway sensory
neuron-ablated and intact mice. To understand how MHV-A59 infection modulates airway sensory neuron
function to promote respiratory disease, I will acquire expertise in two-photon calcium imaging and
electrophysiology to characterize their phenotypic changes in MHV-A59 infected animals. Lastly, I will measure
oxygen saturation, breathing rates, respiratory mechanics and airway hyperreactivity in sensory neuron-ablated
and intact mice to understand how these cells contribute to respiratory dysfunction. These studies will define the
contribution of lung-innervating sensory neurons to coronavirus disease pathogenesis and lay the groundwork
for discovering new treatments for respiratory disease.

Public health relevance
PROJECT NARRATIVE The recent COVID-19 pandemic has underscored a critical need to comprehensively understand how viral infection promotes respiratory disease. This proposal will define the contribution of lung-innervating sensory neurons to airway inflammation and respiratory dysfunction from coronavirus infection. These studies will deepen our understanding of host-pathogen interactions and lay the groundwork for identifying new therapeutic targets for respiratory disease.